SPECT IMAGING OF DOPAMINE RELEASE W/ 123I-IBZM &HETAMINE IN COCAINE ABUSERS

This proposal will provide in two scans a complete characterization of dopamin-ergic function in 45 patients with schizophrenia compared to 45 matched healthy controls. We will compare D-amphetamine induced DA release & AMPT induced DA depletion between patients with schizophrenia compared to healthy controls.